BioImaging Shared Resource

ABSTRACT: BIOIMAGING SHARED RESOURCE (BISR)
The BioImaging Shared Resource (BISR) supports high-end light microscopy needs of Sidney Kimmel Cancer
Center (SKCC) members to accelerate cancer research discoveries. The BISR provides state-of-the art
visualization capabilities, advises and trains users to properly and independently use microscopes, and provides
ready access to reliable light microscopy acquisition tools and data analysis software. BISR staff leverages
decades of experience to counsel and train users on the appropriate imaging system for their research. In
addition to meeting the current needs of SKCC investigators, the BISR is tasked with looking ahead to future
research directions by engaging with researchers and pursuing new technologies to expand the services
available to the Center. Established in 1991, the BISR has been continuously funded by the CCSG since 1996
and currently maintains six well-equipped light microscopy systems, including laser-scanning and spinning disk
confocal, wide-field live-cell imaging, total internal reflection fluorescence (TIRF), and super-resolution
stimulated emission depletion (STED) systems.
The BISR is led by Co-Directors Philip Wedegaertner, PhD and Claudio Giraudo, PhD, each with over 25 years
of experience in BioImaging. Although the Co-Directors work together in the overall administration of the
expanding BISR, Wedegaertner has primary oversight of the confocal imaging equipment and users while
Giraudo oversees TIRF and STED microscopy. The BISR provides cost-effective support for labs by saving
SKCC members the capital required to obtain sophisticated instrumentation and associated service contracts
and by eliminating the need to maintain experienced personnel in each laboratory. The BISR is located in the
Bluemle Life Sciences Building and is easily accessible to all SKCC investigators via a short walk (<1 mile). The
Specific Aims of the BISR are to: 1) Increase user training and educational opportunities to encourage increased
usage of existing and novel light microscopy technologies, and 2) Increase BISR impact through the acquisition
of cutting-edge imaging and data analysis capabilities. During the project period, the BISR served 69 SKCC
members, 42 (60.9%) of which had peer-reviewed funding, representing all four Research Programs. BISR
services were utilized by 92 total users in 49 peer-reviewed publications (average impact factor 8.51) and 18
grant applications.
In line with the SKCC strategic plan, IMPACT PHL, and under the guidance of the Co-Directors and advisory
boards, the BISR has set four goals for future development: 1) Implement an Image Analysis Station and
introduce Quantitative Analysis Training to expand services offered, 2) Acquire a new state-of-the-art confocal
microscope to supplement heaviest use instrument, 3) Develop workshops for all new and potential users,
graduate student courses, and in-house training resources to expand on-site education, and 4) Update existing
instruments to modernize functionality.